Optical Control of the Actin Cytoskeleton

Project Summary/Abstract
The goal of this project is the optical control of the actin cytoskeleton with photoswitchable
molecules. These compounds target monomeric G-actin, polymeric F-actin, the nucleator
complex Arp2/3, and the motor protein myosin II. Our probes aimed at F-actin and G-actin are
derived from the natural products jasplakinolide, yielding opto-Jasp, cytochalasin D (opto-Chal),
and latrunculin B (opto-Lat), respectively. The photoswitchable molecules for Arp2/3 stem from
CK-666 (opto-CK) and the photoswitchable myosin 2 inhibitors from blebbistatin and similar
compounds (opto-MI). We have already obtained significant preliminary results in a variety of
cells (e.g. yeast, HeLa, neurons, oligodendrocytes, microglia). Our proposed program constitutes
the continuation of our long-standing and successful program on optically controlling actin and
tubulin, as well as associated motor proteins with photoswitchable small molecules. The close
collaboration between a chemical biologist and a structural biologist will yield useful probes that
are shared with the community and could form the basis of a new form of precision
chemotherapeutics.

Public health relevance
Project Narrative The goal of this proposal is the development of small molecules that can control actin dynamics with light. Such molecules could serve as useful probes to study the actin cytoskeleton and form the basis of a new class of precision chemotherapeutics.